Training Program in Pediatric Gastroenterology/Nutrition

PROJECT SUMMARY/ABSTRACT
This application is for 8th consecutive renewal of the Ruth L. Kirschstein National Research Service
Award T32 Postdoctoral Research “Training Program in Pediatric Gastroenterology/Nutrition” at the
University of California, San Francisco (UCSF). More than 70% of graduates of UCSF Training Program in
Pediatric Gastroenterology/Nutrition remain productive researchers and academic leaders in their
respective fields The Program aims to train talented and dedicated young physicians to become
independent and productive scientific investigators, and recent graduates have been successful in
progressing along academic career development pathways. These future scientists will research
important health problems, focusing on the causes, pathogenesis, and treatment of digestive, liver and
nutritional disorders in infants and children. Preference is given to trainees committed to a 4-year training
program, including 3 years of research training in either Basic (T1 track) or Clinical/Translational (T2
track) Research mentored by established scientists. The key elements of the proposed training are: (1) a
mentored research experience, (2) scientific course work, (3) career development workshops, (4)
interdisciplinary experiences and (5) ongoing review and evaluation. Basic research experience is
supplemented with coursework, seminars, and inter-departmental retreats; trainees in clinical research
participate in the well-established Training in Clinical Research Program that includes a 1-year Advanced
Training in Clinical Research certificate, leading to a 2-year Master's Degree in Clinical Research
program. Each trainee pursues an obligatory research project(s) supervised by experienced preceptors.
All trainees take courses in Responsible Conduct in Research, Research Rigor and Reproducibility,
Scientific Writing and the Art of Lecturing. The trainee and research mentor determine additional course
work in the specific field of research. Entry requirements include a MD degree and 3 years of residency in
clinical pediatrics. Applicants with a PhD degree and defined career goals related to developmental
gastroenterology or nutrition are also eligible. Administration of the program is restructured to take
advantage of the strengthened Division of Pediatric Gastroenterology/Nutrition under the primary
direction of Dr. Melvin Heyman, associate direction from Dr. Philip Rosenthal, and mentored assistant
direction from Drs. James Bayrer and Emily Perito. The quality of educational and research programs
and activities are closely monitored by trainee mentors, research preceptors, Internal Advisors, the
Assistant Program Directors, the Associate Program Director, the Program Director, and annual
evaluations by distinguished External Advisors. An increase from 3 to 5 training positions is requested in
Years 41-45.

Public health relevance
PROJECT NARRATIVE This Program is directly relevant to child health and development in training the next generation of scientists who will generate the advances essential for improving the quality of life and survival rates of children and adolescents with gastrointestinal, liver and nutrition-related disorders. Further, this training program represents an investment in the future of public health in general, as the multidisciplinary, intensive and innovative training provided by this Program will educate the leaders, teachers, and professional role models who will determine the direction and contributions of American medicine domestically and throughout the world, particularly as relates to pediatric gastroenterology, hepatology and nutrition.